CSR&D Research Career Development Transition Award Application

There is an “epidemic of loneliness” with 20% of civilians and up to 50% of veterans reporting feeling lonely or
socially isolated. This is clinically important because loneliness and social isolation are strong predictors of
worse physical health and early mortality. Mental illness is intimately entwined with this epidemic because it
both causes and is worsened by loneliness and social isolation. It is the social deficits of mental illness that
most strongly contribute to loneliness and social isolation. These social deficits include difficulty understanding
other people’s behavior and difficulty behaving appropriately in social situations. Despite their importance,
these social deficits are poorly understood at the neural and behavioral levels and are difficult to quantify.
Moreover, available treatments for them are inadequate. I am the Director of the Bonding and Attunement in
Neuropsychiatric Disorders (BAND) lab, which comprises one junior faculty member supported by a CSR&D
Career Development Award, 5 postdoctoral fellows including MDs and PhDs, 4 graduate students, 6 paid
research assistants, over 20 volunteers. We believe the key to mental health and well-being starts with
strong relationships. Our mission is to develop novel pharmacological and cognitive interventions for
mental illness that enable patients to strengthen their connections to other people and the world. Our
work has primarily focused on understanding the psychological, behavioral, physiological, and neural effects of
administration of the neuropeptide oxytocin across multiple psychiatric illnesses. For example, we have
conducted numerous studies determining the acute effects of oxytocin administration in individuals with
schizophrenia. One highlight of this work is that we found that a single administration of oxytocin to individuals
with schizophrenia normalized neural activity during high-level social cognitive processing and that this
normalization was associated with improved behavioral performance. This work led to a VA CSR&D Merit
Award to conduct the largest randomized clinical trial of repeated administration of oxytocin in schizophrenia to
date. We have also conducted studies investigating oxytocin as a potential treatment for individuals with
alcohol, opioid, and stimulant use disorders, and co-occurring post-traumatic stress disorder (PTSD) and
alcohol use disorder (a common and difficult-to-treat comorbidity). We also recently completed a large
laboratory-based study in healthy individuals to determine whether acute oxytocin administration can
accelerate the development of team cohesion. This work led us to hypothesize that pharmacological
treatments that affect social processes could be paired with psychosocial treatments to possibly
achieve synergistically positive outcomes. To investigate this possibility, we have conducted studies pairing
administration of various drugs with social effects, including oxytocin, 3,4-methylenedioxy-methamphetamine
(MDMA), and psilocybin, with various psychotherapy interventions including group-based psychotherapy. In
the non-pharmacological arena, we have been investigating attention bias modification delivered through a
smartphone app as a treatment for PTSD. Our studies incorporate multiple analytic approaches including
objective measures of social behavior such as eye-gaze, facial expressivity, team cohesion and performance,
quantification of social cognitive abilities, neuroimaging approaches, laboratory-based craving induction
paradigms, and quantification of psychophysiological changes and interpersonal synchrony. In sum, I have
developed a broad and highly productive trans-diagnostic program of research and assembled a large,
energetic, and multidisciplinary research group focused on developing and testing novel treatments for the
difficult to treat social deficits that cut across most psychiatric disorders. By improving social deficits across
disorders, veterans will have better social functioning and decreased symptom severity and will be able to
more effectively mobilize their social support networks and engage in other psychiatric treatment. This will lead
to better health outcomes and decreased costs for the VA health system.

Public health relevance
The clinical and economic costs of mental illness are significant within the VA. For example, ~4% of veterans suffer from schizophrenia, ~8-31% suffer from PTSD, and ~7-18% suffer from a substance use disorder. Currently available treatments for these disorders are insufficiently effective, are often costly, time-consuming, and associated with significant side-effects, and frequently have poor uptake and adherence. Most mental illnesses are associated with social deficits that lead to social isolation and loneliness, which in turn lead to worse mental and physical outcomes including suicide, despair, and early mortality. Using a multidisciplinary and multi-pronged transdiagnostic approach, my lab is focused on understanding and treating the pathological psychological, neural, and behavioral mechanisms of these social deficits. We hope that by targeting these deficits with novel pharmacological and non-pharmacological interventions, we can revolutionize mental illness treatment within the VA, leading to better clinical outcomes and decreased health care costs.